In Vivo - In Vitro: Repurposing Itraconazole for toplical treatment of Basal Cell

Optimize formulations of topical Itraconazole for absorption by human skin; Test GLP grade formulation on a human BCC model grafted on nude mice. Test GLP grade Itraconazole creams (the 2-3 best candidates from #1 above) vs. placebo on the prevention of actual BCC tumors in Ptch1+/-K14-Cre-ER P53 fl/fl mice.